NEURONAL ORDERING IN A SIMPLE NUCLEUS

A major problem in developmental neurobiology involves determining the rules underlying axonal guidance and the establishment of neuronal order within the vertebrate brain. The failure of neurons to establish the proper connections or the proper type of connections win generally result in sensory or motor deficits. Rules underlying neuronal ordering vary across systems and within a system across species. For this reason, several workers have proposed investigating new models, to separate general principles from systems-specific variations. The goal of the research proposed here is to develop a new model system, the first order electrosensory nucleus (nE) of teleost fishes, for examining the principles of ordering within vertebrates. The nE is a monosensory preparation exhibiting the following features: somatotopic organization, simplicity (only two major cell types that are arranged into discrete laminae), experimental accessibility to its afferent neurons, and, across species, the presence of either a one-map or a four-map nucleus. Immunocytochemical and tract-tracing techniques will be combined to explore six questions concerning the formation of the nE: 1) Where along the neural axis do nE cells arise?; 2) How do the two cell types -- granular and pyramidal cells -- sort themselves into laminae?; 3) Can primary afferents play a role in establishing nE somatotopy?; 4) Does cell death occur?; 5) Do established connections shift target cells with growth?; and 6) How are the one-map and four-map nuclei developmentally related? These results will be interpreted within the context of known models of vertebrate neuronal development.